Computational approaches for protein functional analysis using CRISPR screens

Abstract
The development of a high-throughput biotechnology highly relies on relevant computational methods for
systematic optimization and data analysis. On the other hand, the development of bioinformatics methods
requires in-depth understanding of the biological systems and the experimental protocols. The long-term goal
of our lab is to develop computational methods that can be seamlessly integrated with high-throughput
experiments to address biological questions, with a focus on transcriptional and epigenetic regulations.
Understanding protein functions is a fundamental aim in biology. The recent advances of CRISPR screening
techniques have enabled functional studies of proteins in a high-throughput manner, leading to novel discoveries
beyond the capacity of traditional methods. During the next five years, our short-term goal is to develop
solutions to boost the utilization of high-throughput CRISPR screens for protein functional analysis. To achieve
this goal, we propose three research topics:
1) Prediction of sgRNA knockout effects for improved sgRNA library design in CRSIPR screens. This will
address the bioinformatics needs in the design of CRISPR screens;
2) Protein domain analysis using CRISPR tiling-sgRNA screens. This will lead to innovative solutions for the
studies of protein domain and structure.
3) Inference of transcriptional regulatory networks from CRISPR screen and -omic data. This will lead to the
development of new methodology to address an open problem involving protein-protein interactions and
regulations of transcription factors and epigenetic regulators.
Collectively, the proposed project will contribute new methods to enrich the toolbox for protein functional
analysis, and will provide novel insights into the fields of transcriptional and epigenetic regulations.

Public health relevance
Narrative CRISPR screens hold great promise for the understanding of protein functions in a high-throughput manner. We propose to develop computational methods to address the bioinformatics needs in the design of CRISPR screens, and to repurpose CRISPR screens for innovative solutions to the understanding of protein structure, interaction, regulation and cellular roles. For method evaluation and proof-of-concept applications, we propose to apply the methods to the studies of transcription factors and epigenetic regulators, which are important protein categories involved in physiology and disease.